Regulation of Neuronal GPCR Signaling

PROJECT SUMMARY
G protein Coupled Receptor (GPCR) signal transduction pathways play a pivotal role in the development of
substance abuse. Many drugs of abuse including opioids and psychostimulants produce their effects by
activating GPCRs expressed in generalized brain reward circuitry. Our long-term goal is to elucidate
molecular and cellular mechanisms that govern GPCR signaling and cross-talk as a necessary prerequisite to
understanding events that lead to substance dependence and designing strategies for the therapeutic
correction.
Current research on mechanisms of opioid use disorder focuses heavily on mu-opioid receptors (MOR),
primary target of opioid drugs responsible for their clinically significant effects including analgesia and euphoria.
However, regulatory mechanisms of MOR and its coordination with other GPCRs in neurons in brain reward
circuitry are incompletely understood. Through systematic unbiased genetic screening efforts, we have
discovered that MOR's actions are closely coordinated with a poorly studied orphan receptor- GPR139. We
have identified an endogenous peptide ligand for GPR139 and found that it triggers distinct signaling reactions
to oppose MOR effects on behavior. This sets an unprecedented opportunity to understand mechanisms of
GPCR cross-talk in neuronal reward circuit while studying how it affects opioid actions at molecular, cellular,
and behavioral levels.
Based on accumulated data we hypothesize that GPR139 antagonistically intersects with MOR at multiple
levels that include activation of unique set of G proteins, coordinated recruitment of -arrestins and
convergence at the downstream effector level by modulating second messenger cAMP and activity of ion
channels regulating activity of neurons in key structures involved in reward processing and opioid actions. This
hypothesis will be tested by pursuing three complementary Specific Aims that seek to (1) understand
molecular mechanisms of GPR139 regulation and its interplay with GPCRs, (2) determine mechanisms of
GPR139 actions in regulating neuronal activity and (3) probe behavioral and circuit relevance of GPR139
influence in controlling responses to opioids. The strategy proposed to address these Aims will entail a
synergistic combination of genetic, biochemical, and physiological approaches, exploiting a powerful array of
reagents, animal models, and innovative assays. We hope that by focusing on GPR139 as a new target,
completion of these studies will offer means for altering processing of opioid signals advancing the overall goal
to develop therapeutics for opioid use disorder.

Public health relevance
PROJECT NARRATIVE Drug addiction is a disorder of the brain that puts a heavy burden on the society. Studies proposed herein are aimed at understanding molecular mechanisms controlling the function of the neuronal signaling systems that mediate the effects of adictive drugs. It is anticipated that the results will facilitate the design of novel strategies for the treatment of opioid use disorder and neurological diseases.